Drug Design and Synthesis Core

SUMMARY
The Drug Design and Synthesis Core (DDSC) is key to the mission and overall success of the COBRE Center
for Targeted Therapeutics (CTT) and made key contributions to the success of Phases 1 and 2. Its mission is
to provide expertise to investigators in evaluation of biological targets for druggability, to assist them in
synthesizing chemical analogs that can be used in drug development and furthermore in designing viable
strategies for drug discovery and optimization. DDSC is the only chemical synthesis core facility operating at
USC and provides unique services to interested investigators. In accomplishing the specific aims, the DDSC will
enable investigators to maximize the funding potential and scientific outcomes of their research progress while
leading to potential new therapeutic options for challenging diseases, conditions, and illnesses.